The Molecular Vector Physiology Laboratory at New Mexico State University

Project Abstract
We request supplemental support for the purchase of a “Micro Clima-Series™ Premium ICH
Insect Chamber” from Snijders Labs to further the research capacity of the MVP lab. This
machine has unique and specific features that will allow for in-depth investigation on the impact
of environmental conditions on mosquito development, adaptation, vectorial capacity, and adult
mosquito mating and feeding behaviors. It will enable us to simulate diverse and dynamic
diurnal environments with precise changes in temperature, humidity, and lighting. We propose
three scientific aims that the “Micro Clima-Series™ Premium ICH Insect Chamber” will enable
our research program to investigate:
- Aim 1: Vectorial capacity of mosquito vectors in the lens of the five IPCC climate change
scenarios.
- Aim 2: Adaptations of a tropical mosquito vector, Aedes aegypti, in cooler climates of
North America.
- Aim 3: Optimizing male mosquito fitness for Sterile Insect Technique.
These aims fall within the scope of the parent award to perform high quality research on
disease-transmitting mosquitoes, educate future leaders in the field of vector biology, and
develop novel methods for mosquito control.

Public health relevance
Project Narrative We request supplemental support for the purchase of a “Micro Clima-Series™ Premium ICH Insect Chamber” from Snijders Labs to further the research capacity of the MVP lab. This machine has unique and specific features that will allow for in-depth investigation on the impact of environmental conditions on mosquito development, adaptation, vectorial capacity, and adult mosquito mating and feeding behaviors. It will enable us to simulate diverse and dynamic diurnal environments with precise changes in temperature, humidity, and lighting.